Endothelin-1 in Obesity and Insulin Resistance

Project Summary
Obesity is an epidemic that affects over 40% of the United States and leads to a high risk
of development of diabetes. As adipose tissue expands, several cellular and molecular
pathways are altered leading to adipocyte dysfunction and insulin resistance. Black
Americans are at an even greater risk of developing cardiovascular disease and type 2
diabetes compared to white counterparts; however, the mechanisms are not understood.
Our lab has shown that the peptide endothelin-1 (ET-1) is elevated in obesity and
treatment with ET-1 antagonists improve glucose and lipid homeostasis in obese mice.
Adipocyte specific knockout of the ET-1 type B receptor attenuates obesity induced
dyslipidemia and insulin resistance in mice. Interestingly, black Americans have higher
circulating ET-1 compared to white Americans suggesting a potential mechanism and
target to improve metabolic syndrome in black Americans. This administrative
supplement will support the career development of Ms. Haley Murphy as she aims to
determine the intracellular pathways by which ET-1 causes adipocyte dysfunction in
obese mice in pre-clinical experiments. Second, she will establish a pathway to clinical
research by performing single nuclear RNA sequencing on de-identified visceral adipose
tissue samples to determine differences in the cellular makeup of adipose tissue from
obese black and white Americans.

Public health relevance
Project Narrative Obesity is characterized by an expansion of adipose tissue and is a major risk factor for the development of insulin resistance and type II diabetes. Endothelin-1 is thought to contribute to insulin resistance and is increased in patients with obesity as well as in black vs. white populations. The current proposal will elucidate mechanisms by which ET-1 contributes to insulin resistance on fat cells and will provide data on the differences in cells that make up the fat tissue of black and white patients with obesity.